UCSF Environmental Research and Translation for Health Center (EaRTH Center)

ABSTRACT - OVERALL
Established in 2020 with a goal to accelerate the pace of discovery and translation of the environmental
impacts on health and susceptible populations, the UCSF Environmental Research and Translation for
Health (EaRTH) Center produces ground-breaking research, innovations and engagement leading to systemic
solutions preventing harmful exposures and improving health equity. Based at one of the top medical and
research universities, EaRTH has grown to 91 researchers, 5 labs and co-labs, and generated $69 million in
new environmental health funding. Our membership spans 21 departments in all 4 UCSF professional schools,
UC Berkeley and Santa Cruz. Our high impact in a relatively short time includes 101 papers published (21
in top 5% for attention in Altmetric), new laboratory and research methods to identify harmful chemicals, and
scientific discoveries informing evidence-based policies on PFAS and other toxic chemicals. We attracted new
researchers and clinicians to environmental health research and our pioneering environmental health medical
materials reached every UCSF medical student and informed clinical guidance for OBGYNs nationally and
globally. EaRTH’s theme is to identify and quantify environmental exposures and how they influence health.
We focus on vulnerable periods of development and in highly exposed populations. We integrate basic,
epidemiological, and translational science with clinical medicine and connect scientific findings into improved
clinical care and public policies. Our target audiences are healthcare learners and professionals and California
policymakers. Our translational vision prioritizes transdisciplinary research that bridges critical knowledge
gaps to accelerate transforming evidence into actionable clinical practices and public health policies to improve
health. Our goals are to: 1) Catalyze new environmental health research by providing expertise,
technologies, and tools; 2) Foster collaborations between historically-separated scientific, clinical, policy and
community groups; 3) Mentor and grow the next generation of environmental health researchers and clinical
leaders; 4) Accelerate health-positive systemic change by sharing our science with decisionmakers to
inform evidence-based clinical care and public policies. EaRTH is led by a strong Administrative Core in
collaboration with our three Center cores and a Pilot Project Program: A) Translational Research Support Core
provides consultation on all aspects of research design, implementation, translation and communication; B)
Bioassay Facility Core offers state-of-the-art tools for 1) biomonitoring; 2) high-throughput screening, and 3)
organoid screening; and 4) guidance to ‘omics technologies; C) Community Engagement Core empowers
health professionals and learners with scientific tools to improve environmental health literacy, promote health
equity, and connect health providers, scientists and community leaders with policymakers; and D) Pilot Project
Program grows the next generation of environmental health researchers and clinicians by funding
transdisciplinary projects and mentorships.

Public health relevance
NARRATIVE - OVERALL Established in 2020, the UCSF Environmental Research and Translation for Health (EaRTH) Center has become a beacon for multi-disciplinary research, innovation, and engagement. With a focus on vulnerable periods of development and highly exposed populations, EaRTH has made significant achievements through high impact published papers, novel laboratory approaches, and evidence-based clinical improvements and public policies. Through partnerships, state-of-the-art infrastructure, and a transdisciplinary approach, EaRTH will continue to catalyze new research, foster collaborations, mentor the next generation of environmental health researchers, and accelerate health-positive systemic change.